Administrative Core

TD Wang and KR Oldham will serve as Project Lead and co-Lead, respectively, for the Admin Core. This
Core will provide administrative support for the Center to fabricate microsystems devices, assemble fiber-
coupled microendsocopes, and develop image analysis algorithms. These efforts include distribution of
funding, preparation of progress reports, scheduling of meetings, arrangement of video conferences,
dissemination of results, announcement of activities, maintenance of the Center website, and arrangement of
travel. A Steering Committee will include Project Leads and co-Leads of the TRD projects, TTD Core, and
Admin Core. An External Advisory Committee (EAC), including a chairperson and several outside experts, will
provide oversight and directions, identify new areas of collaboration, and mediate any conflicts that arise. The
Admin Core will coordinate Center efforts between the School of Medicine and College of Engineering at the
by supporting interactions among the TRD Projects, CP/SPs, TTD Core, Steering Committee, and EAC.
The Admin Core will support outside investigators over a national geographical distribution to engage in
CP/SPs. These funded PIs will present new biomedical challenges to serve as testbeds for the microsystems
solutions being developed in the TRD projects. The interactions will drive Center technologies toward new
directions and for broad biomedical applications. The Center will be located in space behind the animal barrier
that includes imaging suites and adjacent surgical procedure rooms to prepare small animals for imaging. A
nearby vivarium will provide housing for animals used in longitudinal investigations. The adjacent CMI Core
facility provides a wide variety of whole body imaging systems, including MRI, PET, SPECT, CT, ultrasound,
bioluminescence, fluorescence, and photoacoustic, to collect multi-modal images to validate the optical
sections collected with in vivo microendoscopy. Cost-share funds have been provided as seed funds to
establish new CP/SP projects to further advance the Center mission.
The Admin Core will support CP/SP investigators to prepare experimental protocols to use the
microendoscopes for in vivo imaging in small animals. Prospective users will provide the aims of the proposed
studies, and will include specific details about the in vivo imaging procedures. The use of animals, species,
and planned numbers will be justified. Use of the operating software and image analysis algorithms will be
covered. The UM Institutional Animal Care & Use Committee (IACUC) will review the protocols for final
approval. Research animals will be sent to the Center, and housed in the vivarium for longitudinal pre-clinical
imaging studes. CP/SP investigators will be supported to prepare regulatory documents to use Center
microendoscopes in clinical studies. An abbreviated IDE will be assembled to obtain FDA approval to use
Center instruments in human subjects. Protocols will be developed to sterilize the Center microendoscopes to
allow for repeat use in clinical procedures for up to n = 20 times.